Strengthening Screening and Referral Systems to Address Early Childhood Obesity Risk

PROJECT SUMMARY/ABSTRACT
Disparities in weight outcomes begin in infancy and persist across the lifespan, fueling obesity rates and its
comorbid diseases. Most current prevention strategies are narrow in scope, coaching parents to invest
substantial effort into managing their infant’s feeding and activity practices. These approaches face limitations
in families with financial challenges, as they compete directly with efforts to manage co-existing food, housing,
or utility needs. Social risks account for up to 27.4% of obesity outcomes, yet only 1.6% of strategies target
them. The Medicaid Section 1115 Demonstration Waiver enables each US state to customize its Medicaid
program to tailor disease prevention for its specific population. Researchers have shown that screening for
social needs — adverse social conditions unevenly distributed across racial and ethnic communities — may be
more effective than genetics screening in predicting health outcomes. Subsequently, New York state was
awarded a temporary Waiver to reimburse health and community systems for social needs screening and
resource connections, with targeted eligibility for early maternal-child health. This proposal represents a rare
and scientifically significant opportunity to identify policy strategies that may prevent racial, ethnic, and
socioeconomic disparities in obesity. We propose a strategic study design that capitalizes on the time-sensitive
window to evaluate New York’s Medicaid 1115 Waiver, set to expire on March 31, 2027. This proposal’s
overall goal is to evaluate impacts of New York’s Waiver Demonstration on early obesity risk in New York City
Health + Hospitals, the largest US public hospital system. Our specific aims are: 1) Evaluate whether a greater
degree of Waiver exposure is associated with healthier weight outcomes, as well as healthier infant feeding
and activity practices; 2) Describe stakeholder attitudes and perspectives on facilitators and barriers to Waiver
implementation. AIM 2’s qualitative exploration will identify contextual factors that influence real-world
implementation, informing the predictive framework in AIM 3; 3) Assess trends in infant weight outcomes
before and after Waiver implementation and evaluate how stakeholder-identified facilitators and barriers from
AIM 2 may influence Waiver impact. This proposal draws upon world-class clinical, research, and teaching
resources available at NYU Grossman School of Medicine, New York City Health + Hospitals, and Stanford
University School of Medicine. The PI has assembled a scientific team comprised of leading experts in
pediatrics, health services research, social determinants of health, advanced biostatistics, epidemiology, early
childhood obesity disparities, and policy implementation. This urgent research will provide actionable insights
for other states considering similar Waivers and support integration of social needs into obesity prevention.

Public health relevance
PROJECT NARRATIVE Identifying policy strategies to prevent racial, ethnic, and socioeconomic disparities in obesity that begin in infancy is a public health priority. This study uses an early childhood obesity framework to assess a temporary New York Medicaid policy that reimburses health and community systems for social needs screening and resource referrals, with a focus on early maternal-child health eligibility. Completion of these aims will fill critical gaps in our policy knowledge, guiding other states actively considering similar policies, and inform future prevention strategies to decrease obesity disparities across the life course.